Reducing Vaccine Hesitancy among Hispanic Parents of COVID-19 Vaccine-Eligible Children

Project Summary/Abstract
COVID-19 vaccines, currently available to children over six months old, are a powerful method of preventing
new infections and reducing the risk of hospitalization and death due to COVID-19. However, vaccination rates
among Hispanic children remain suboptimal. Lower vaccination rates in children are largely due to parental
vaccine hesitancy. While national health communication experts have suggested using storytelling as an
effective intervention strategy to promote COVID-19 vaccination, we will take the innovative next steps of
creating and evaluating a digital storytelling intervention to reduce Hispanic parental vaccine hesitancy.
Working with community health workers, we will engage Hispanic parents and legal guardians who report
being previously hesitant to vaccinate their child(ren) against COVID-19 to serve as our digital storytellers.
We will ask them to share their stories of conversion in COVID-19 vaccine perspectives to help other
parents and legal guardians overcome their unique concerns and mistrust of COVID-19 vaccines. Guided by
the Theory of Planned Behavior and storytelling as culture-centric health promotion, we propose to (Aim 1)
develop culturally-relevant digital stories (each 2-3 minutes long) with a diverse sample of Hispanic parents
and legal guardians who transformed from being COVID-19 vaccine-hesitant to vaccine-accepting. In Aim 2,
we will assess the feasibility and acceptability of a web-based pilot digital storytelling intervention vs.
information-only control among parents and legal guardians (n=80) of children who are not up-to-update with
COVID-19 vaccine doses. We will also explore pre- to post-intervention changes in vaccine perceptions,
vaccine hesitancy, intentions to vaccinate children against COVID-19, and children’s vaccine uptake at two-
month post-intervention. If our study demonstrates feasibility, acceptability, promising reductions in vaccine
hesitancy, and increases in vaccine uptake, we will conduct a full-scale randomized controlled trial to examine
the effectiveness of the DST intervention to reduce COVID-19 vaccine hesitancy in our target population. This
more extensive study could be used in future DST interventions to increase immunizations (e.g., flu, HPV)
among Hispanic children and adolescents. In addition, our innovative research may provide evidence of
scalable, disseminatable strategies to reduce vaccine hesitancy and can be used for other rapid vaccination
efforts for potential future outbreaks.

Public health relevance
Project Narrative Although vaccinating children and adolescents against SARS-CoV-2 (COVID-19) can prevent complications and hospitalizations due to this virus, COVID-19 vaccination rates among Hispanic children remain suboptimal primarily due to parents’ hesitancy to vaccinate their children. Our community-based study aims to create and evaluate a disseminable, low-cost intervention to reduce Hispanic parents’ vaccine hesitancy. This study addresses the significant public health problem of children’s infection with COVID-19 and aligns with the NICHD’s target area of developing and evaluating community-engaged interventions to promote vaccine uptake among children and adolescents.